CORE SUPPORT FOR A CANCER RESEARCH CENTER

This request for CORE support is based on the desirability of maintaining and improving a research resource in the fundamental aspects of radiation oncology now in existence at this institution. Although all individual research projects presently associated with the Divisions of Radiation Biology and Radiologic Physics have been subject to peer review and are funded by separate grants, they also have a common primary objective -- namely, the study of the basic nature of and the detection and treatment of cancer through the use of radiation. A perhaps less important but inseparable objective of the staff associated with these endeavors has been the education and training of individuals specializing in various aspects of radiation effects and ranging from pre-doctoral graduate students to post-doctoral investigators and Residents in Radiology. Funding aimed at supporting (1) common service type mechanical shops, tissue culture facilites, library, and administration, etc., (2) salary support for staff investigators, (3) modest but critical developmental research support (4) encouraging cooperative research between basic scientists and clinicians and (5) guiding the design of preclinical and clinical trials of new concepts should materially improve the efficacy of the personnel and eventually increase research contributions in radiation oncology. All these aims are to be coordinated by a Cancer Center Organization that will also recommend and promulgate similar objectives for the Case Western Reserve University and University Hospitals.